HEALTH AND ADJUSTMENT OF IMMIGRANT CHILDREN AND FAMILIES

The Contractor shall convene a committee to synthesize and supplement the available knowledge base on a range of issues associated with the health and mental health of immigrant children and families.